Healthy Native Babies Project

This is an interagency agreement (IAA) between the Centers for Disease Control and Prevention (CDC), National Center for Chronic Disease Prevention and Health Promotion (NCCDPHP), Division of Reproductive Health (DRH) and National Institute of Child Health and Human Development (NICHD) to collaborate on the Healthy Native Babies project (HNBP). About 3,400 babies in the United States die suddenly and unexpectedly each year. Sudden Unexpected Infant Death (SUID) includes Sudden Infant Death Syndrome (SIDS), accidental suffocation in a sleeping environment, and other deaths from unknown causes. Average annual SUID rates (2015-2019) per 100,000 live births were highest among non-Hispanic American Indian/Alaska Native (Al/AN) (216.0); almost triple the SUID rate among non-Hispanic White infants (84 per 100,000 live births). This project is expected to achieve, but is not limited to, the following outcomes for American Indian/Alaska Native (Al/AN) communities: A) Increase understanding of infant safe sleep guidelines to reduce the risk of SIDS/SUID; B) Contribute to improved outcomes for Al/AN infants.